MIZ1 Activation in Triple-negative Breast Cancer Racial Disparities

Triple-negative breast cancer (TNBC) is an aggressive and molecularly heterogeneous subtype of breast cancer
that frequently exhibits resistance to chemotherapy leading to poorer clinical outcomes. African American (AA)
women in the United States not only suffer from higher incidence rates of TNBC as compared to their European
American (EA) counterparts, but they also endure poorer survival outcomes. Racial disparities in TNBC
outcomes are multifactorial and not fully explained by treatment variations and socioeconomical inequalities. As
such, investigations into how the pathophysiology of TNBC differs between AA and EA women may offer new
insights into the manner through which biologic and socio-demographic factors converge in creating outcome
disparities in TNBC. By sequencing the transcriptomes of primary TNBC tumors obtained from 3 independent
patient cohorts, we detected aberrant activation of MIZ1 in ~70% of AA tumors, an event that was strongly
associated with poorer overall survival solely in AA patients. Based on these and other compelling findings, we
hypothesize that (i) MIZ1 activation underlies disparate outcomes and poor overall survival rates of AA women,
and (ii) targeting mechanistic vulnerabilities in MIZ1 signaling will provide for novel therapeutic approaches to
significantly improve AA TNBC outcomes. To test this hypothesis and to elucidate the molecular mechanisms
whereby MIZ1 governs TNBC aggressiveness in AA patients, we endeavor to perform the following Specific
Aims: (1) determine the mechanisms whereby MIZ1 drives AA tumorigenicity; (2) determine the mechanisms
whereby MIZ1 impacts cellular heterogeneity and macrophage polarization of AA TNBC tumors; and (3)
determine the association of African ancestry with MIZ1 activation in AA TNBC and define the role of this event
in TNBC progression. This project marks the first effort to harness mechanistic vulnerabilities in MIZ1 activation
and function to improve clinical outcomes of AA TNBC patients. Collectively, our innovative concept is highly
impactful and could potentially redefine the clinical practice of treating AA TNBC patients, doing so by developing
novel biomarkers, new drugs, and drug targets to improve clinical outcomes of AA TNBC patients.

Public health relevance
Triple-negative Breast Cancer (TNBC) is more common and exhibits higher aggressiveness in African American women as compared to their European American counterparts, with socio-economic and lifestyle factors being unable to fully account for this significant racial disparity. Our proposed studies will delineate the molecular mechanisms associated with TNBC aggressiveness with an overarching goal of identifying the etiologic factors contributing to outcome disparities in African Americans. Our proposed studies will also unravel novel surveillance and therapeutic avenues, thereby guiding and improving the clinical management of this deadly disease.